New Catalysts, Strategies and Methods for Stereoselective Chemical Synthesis

Project Summary:
Stereochemically defined organic molecules play a crucial role in drug development and
advances in medicine. Catalytic, efficient, selective, broadly applicable, practical (scalable)
methods that provide access to such entities, and that are sustainable and cost effective (e.g., no
precious metals) are much needed and in great demand. Despite notable recent advances, existing
methods for the preparation of important bioactive compounds often do not satisfy many of the
above criteria. The principal goal of this program is to design catalysts, and develop methods that
address the above issues.

Public health relevance
Project Narrative: Catalysts provide access to otherwise inaccessible compounds, and do so with minimal energy expenditure and waste generation. We will develop new catalysts and methods for preparation of bioactive molecules with maximum efficiency and minimal cost.